Advancing Rehabilitation Paradigms for Older Adults in Skilled Nursing Facilities

Project Summary Abstract (from funded parent award)
In the U.S., 8.37 million adults over age 65 will experience a hospital stay during the next year, which often
has serious and long-lasting consequences including profound deterioration in physical function. Following a
hospital stay, around 1.35 million patients with deconditioning require rehabilitation in a skilled nursing facility
(SNF) each year to address the deleterious musculoskeletal and functional deficits from deconditioning.
Unfortunately, current rehabilitation paradigms in SNFs do not adequately restore physical function, which
directly contributes to poor community discharge rates. Strikingly, only 52% of all patients admitted to SNFs
are discharged to a community setting (e.g., home), which suggests a paradigm shift is required to optimize
rehabilitation within SNFs. Currently, usual care rehabilitation in SNFs consists of low-intensity rehabilitation
interventions, which are physiologically inadequate to induce meaningful changes in skeletal muscle strength
and physical function. To address these pitfalls, a high-intensity resistance rehabilitation paradigm has been
shown to improve outcomes including better physical function, increased community discharge rates, and
cost-effective reductions in length of stay. The proposed pragmatic study seeks to apply this rehabilitation
paradigm to multiple SNFs to further evaluate the effectiveness of high-intensity resistance rehabilitation (Aim
1), while evaluating processes, mechanisms, and determinants of successful implementation (Aim 2). We
propose a cluster randomized pragmatic trial design in which a high-intensity intervention (15 SNFs) will be
compared to usual care (15 SNFs). Effectiveness in terms of physical function will be determined via change
in patient gait speed (primary outcome) from admission to discharge. Implementation strategies will be
evaluated by reach (proportion of patients treated with the intervention), adoption (proportion of therapists
appropriately adopting the intervention), implementation (fidelity assessments), and maintenance (long-term
fidelity assessments) of the intervention. This study will provide the first large-scale evaluation of high-
intensity rehabilitation for patients admitted to SNFs following hospitalization. Additionally, through systematic
comparison and in-depth analysis of implementation across a variety of SNFs, this study will provide critical
insight regarding barriers and facilitators of implementation. Overall findings from this study have the potential
to 1) shift SNF rehabilitation care paradigms; 2) optimize patient outcomes
and independence and 3) critically
inform future work aimed at wide-scale implementation of high-intensity rehabilitation across post-acute
settings.

Public health relevance
PROJECT NARRATIVE (from funded parent award) This study seeks to provide large-scale, foundational evidence that high-intensity rehabilitation is effective and can be systematically implemented to improve functional outcomes for patients admitted to skilled nursing facilities following hospitalization. Additionally, this study will generate a descriptive overview of factors that predict implementation success while informing effective implementation strategies for future skilled nursing facilities innovation. Overall, this study is a critical step in advancing clinical practice to establish high-intensity rehabilitation as an effective standard of care in skilled nursing facilities to shift current treatment away from low-intensity, conservative interventions.